FREQUENCY OF ONSET OF ADRENAL HYPERPLASIA IN PATIENTS WITH SEVERE ACNE

To determine the frequency of late onset adrenal hyperplasia in patients whose acne is severe enough that they are being started on Accutane or have failed Accutane therapy.